Genomics, EHRs, GPUs, and Next Generation Computational Statistics

Abstract
The future challenges of statistical genetics are enormous. Data sets continue to grow; studies with 106 cases
and 107 markers have become feasible, but current algorithms and software do not scale to this size. We need to
rethink and rebuild many of our statistical analysis techniques and tools to scale effectively. In addition, health data
will soon be commonly collected from mobile and wearable devices, dramatically increasing its volume and utility.
Precision health and predictive medicine raise the stakes even further. Concurrently, the nature of computing
is rapidly changing. To take advantage of hardware advances, particularly ubiquitous parallel computing, new
statistical approaches and algorithms and new programming paradigms must be brought online.
This renewal proposal targets the application of state-of-the-art statistical techniques and tools to develop
genetic analysis algorithms that can scale to studies with millions of subjects, such as the US Department of
Veterans Affairs' Million Veteran Program (MVP) and the UK Biobank. Biobank-scale data sets have many ben-
eﬁts, particularly the potential power to detect the subtle effects of each of the many genes involved in common
diseases. Another beneﬁt is that these data sets can be more representative of the populace by including large
numbers of people from multiple ancestries, different social strata, and all sexes. To effectively and efﬁciently
analyze these massive data sets requires advances in the current statistical genetics tools. Effective statistical
analysis takes many forms: algorithms that converge in fewer iterations, powerful statistics that accommodate all
available data, and computational methods that take advantage of massively parallel computing hardware such
as graphics processing units (GPUs) and other coprocessors. We will deliver algorithms that can directly handle
biobank-scale data sets for many computationally-challenging statistical genetics tasks, including genome-wide
association studies (GWAS) with trait data from electronic health records (EHRs). More generally, our algorithm
focus will beneﬁt all scientiﬁc ﬁelds driven by computational statistics and high-dimensional optimization.
Of course, for statistical algorithm development to be immediately useful it must be accompanied by fast,
easy-to-use software. We will promptly deliver open-source software that (1) enables interactive and reproducible
analyses with informative intermediate results, (2) provides quality graphics, (3) scales to big data analytics, (4)
embraces parallel and distributed computing, (5) adapts to rapid hardware evolution, (6) allows cloud computing,
and (7) fosters easy communication between clinicians, geneticists, statisticians, and computer scientists. Recent
breakthroughs in computer languages bring all these goals within reach.
Our overall objective is the design and construction of state-of-the-art statistical genetics algorithms and
software for modern, massive genetic and EHR data. Numerical accuracy, computational efﬁciency, and software
sustainability are our priorities. We will deliver a uniﬁed, cross-platform, high-level, reproducible, interactive
analysis environment that is fast and efﬁcient even for biobank-scale data sets.

Public health relevance
Project Narrative The human genome project and electronic health records (EHRs) have dramatically increased the amount of genetic data. In fact, our ability to collect genetic information has far outstripped our ability to make use of this information in understanding the basis of human disease and diversity. Our aim is to design, develop, and distribute new, more efﬁcient statistical and computational approaches that make full use of the vast amount of genetic data, and thus improve genetic researchers' ability to map and characterize genes that lead to human diseases and to trait variation.